BLRD Research Career Scientist Award Application

Current Research and Intellectual Property advancement in the laboratory focuses on bacterial infections that
result (paradoxically) from the use of antibiotics. Our studies are performed under a One Health strategy that
aims to expand interdisciplinary collaboration in diverse aspects of healthcare for humans and other animals.
Our VA and University Affiliate teams are thus focused on elucidating pathogenic mechanisms in the anaerobic
human and veterinary pathogen Clostridioides difficile, as well as the diarrheal disease organisms
Enteropathogenic and Enterohemorrhagic E. coli. Ongoing studies include comprehensive epidemiological and
mechanistic interrogation of C. difficile infection (CDI). Specifically, we have (1) prospective CDI surveillance in
Southern Arizona VA and non-VA hospitals that has resulted in one of the only curated, fingerprinted and fully-
cataloged C. difficile biorepositories in the Southwestern US; (2) developed precision genomics and proteomics
approaches to identify factors contributing to the heightened virulence of newer strains of C. difficile; and (3)
leveraged the information from (1) and (2) to develop multiple, novel C. difficile anti-infectives including targeted
and bio-controlled live biotherapeutics as well as narrow-spectrum antimicrobials. Our VA Merit awards have
resulted in one issued, and two Provisional, Patents as of December 2020.
There are two over-arching goals of the activities described above. The first is to improve the health of Veterans
and, indeed, the elderly and immunocompromised, by developing safe, oral, cost-effective anti-infective
technologies that can transition expediently from the pre-clinical pipeline and into the community. The second is
to continue to partner with VA, national and international Collaborators and train mentees such that current efforts
can be channeled into a legacy plan for anti-infective research both at the SAVAHCS station as well as the
University Affiliate.
This renewal RCS application is thus envisaged as critical to the continued building of relationships within and
outside the Southern Arizona VA Healthcare System community. Our research record underscores the power of
cross-disciplinary science, and the RCS platform has enabled engagement with diverse research groups and
fostered new avenues of investigation. Core values that have been cultivated via these collaborations include
active listening, inclusive discussion and thoughtful communication.
Training and Mentoring is an integral aspect of the PIs’ professional vision, and the current RCS cycle has
provided opportunities to work with diverse and outstanding trainees and mentees. These have included (and
continue to include) first-generation college students, members of under-represented minorities, early-career
Faculty, and Physician-Scientist trainees.
Taken together, RCS activities are envisioned to continue fostering focused and substantive contributions to the
betterment of Veterans’ health via the development of products and technologies aimed at ameliorating
healthcare-associated infections.

Public health relevance
The Veteran population is greatly impacted by Clostridioides difficile infection, a bacterial disease that particularly targets the elderly. Our research has three major foci supported by epidemiology, genetics, and translational components. First (epidemiology), we assess the prevalence of C. difficile infections in the Veteran population in Southern Arizona and provide feedback to clinicians with the goal of reducing disease incidence. Second (genetics), we use cutting-edge molecular techniques to understand the virulence mechanisms of C. difficile, especially strains from VA patients. Third (translational), we leverage this knowledge to develop, precision- focused, non-antibiotic interventions for mitigating C. difficile infection in Veterans/susceptible populations.